NIAID Clinical Products Center (CPC): HIV/AIDS Study Support

The Clinical Product Center contract provides Investigational Product Services for NIAID-funded and/or sponsored clinical research programs. Investigational Products to be studied include schedule I through VI pharmaceutical agents, biologics, and other agents. This project supports product services for NIAID Division of AIDS-funded clinical trials through the ACTG network.